CAM Research Training in Neuroscience & Stress

PROJECT SUMMARY
The CAM Research Training in Neuroscience and Stress T32 program will continue to
utilize ongoing cross-institutional collaborations to provide a multidisciplinary setting for
training both basic and clinical CAM researchers. Oregon Health & Science University
formally houses the training grant and most of the faculty across multiple departments,
but some faculty have primary appointments at the Linus Pauling Institute at Oregon
State University and the National University of Natural Medicine. The CAM research
training program will build upon other NIH funded educational programs located at
Oregon Health & Science University and has access to many excellent core resources
including, most importantly, the Oregon Clinical and Translational Research Institute
that is sponsored by a Clinical and Translational Science Award. The positions funded
will be 6 positions per year for fellows recently obtaining a clinical doctorate degree or a
PhD, targeting approximately equal numbers of clinical and basic science researchers.
The mentors include many established researchers who have done funded research in
areas of CAM along with neuroscience or stress. There are additionally some less well-
established CAM researchers and well-established non-CAM researchers who will be
part of the program. To ensure adequate mentorship, those trainees wanting to do
research with these faculty will be assigned dual mentors to ensure high quality
research in a CAM-related project. This training program will continue the tradition of
cooperation amongst the CAM and neuroscience community in Oregon and at OHSU
that has led to strong research and educational programs and that fosters collaborations
across departments, schools and institutions. The specific activities of the T32 program
include coursework, a focused journal club, an annual retreat, and in depth research
training with mentors’ laboratories. Trainees will learn scientific writing, specific
research methodologies individualized for each trainee and have guidance on their
career planning. In addition, trainees coming from this program will have the ability to
interact with those who do CAM research in neuroscience or stress, be it at the cellular,
whole animal, or human level of analysis, and to understand the scientific literature from
all of these areas.

Public health relevance
PROJECT NARRATIVE This institutional training grant will provide stipends for post-doctoral trainees wishing to pursue a career in research to better understand the mechanisms or the utility of complementary and integrative health approaches to maximize nervous system health or treat dysfunction/disorders of the nervous system including those related to stress. The trainees will learn from formal classroom settings, monthly journal clubs, annual retreat, and from working closely with their successful primary and co-mentors.